THYROTROPIN RELEASING HORMONE AND PREVENTION OF CHRONIC LUNG DISEASE

This study will test the response to TRH among infants treated antenatally with corticosteroids and postnatally with surfacant to evaluate both benefit and possible adverse effects.